Supplement of HL131017: Myocardial remuscularization by cardiac patch delivery of epicardial FSTL1 and CCND2 overexpressing cardiomyocytes

Title:
Supplement of HL131017: Myocardial remuscularization by cardiac patch delivery of epicardial FSTL1
and CCND2 overexpressing cardiomyocytes
Project Summary
Despite undergoing intensive treatment regimens, patients with severe acute myocardial infarction (AMI) often
end up with end stage congestive heart failure (CHF). From the molecular and cellular perspective, heart failure
occurs due to the loss of the contractile unit of the left ventricle: cardiomyocytes (CMs). Therefore, promotion of
myocyte proliferation and understanding the regulators of myocyte cell cycle could have highly significant impact
on the management of heart failure. In this proposal, we seek to develop 3D bioengineered cardiac muscle
constructs that incorporate a functional vascular network and recapitulate some of the key microenvironmental
cues of native heart tissue. Our recent studies have identified main biomechanical and molecular cues that can
significantly enhance cell cycle re-entry of adult CMs. We demonstrated that epicardial application of a cardiac
patch, laden with follistatin like-1 (FSTL1) protein, protected the mouse and pig heart against AMI, left ventricle
dilatation, and heart failure. We recently reported that overexpression of a cell cycle gene, CCND2 (cyclin D2),
induces proliferation of transplanted human induced pluripotent stem cell (hiPSC) derived-CMs. This proposal
builds upon our recent technological achievements, enabling cast or bioprinting of major cardiac cells and
hydrogels at high spatial resolution (20 µm) to fabricate 3D perfusable vascular constructs. Our central
hypothesis is that 3D cardiac constructs, laden with FSTL1 and hiPSC-CCND2 CMs, can synergistically
remuscularize ischemic myocardium. We test this hypothesis in three integrated Specific Aims (SAs). In SA1,
we will utilize our cast/bioprinted 3D cardiac tissue models to identify the cellular and molecular mechanisms
underlying myocyte pro-proliferative effect of FSTL1 treatment in vitro. In SA2, we will assess the identified
signaling pathways, involved in FSTL1-CCND2 CM-patch effect, to promote remuscularization in mouse model
of MI (both acute and chronic). In SA3, we will assess the pre-clinical potential of bioengineered pre-vascularized
muscle patch device in treating AMI in a pig model of ischemia-reperfusion. The open chest delivery of cardiac
patches have imitations. We will compare the efficacy of open chest delivery versus a novel minimally invasive,
catheter-based, pericardial delivery of FSTL1 and CCND2 CM laden muscle patch to the epicardium. The findings
of this project will establish a novel generation of personalized cardiac patch devices for remuscularization of
heart with postinfarction LV remodeling.

Public health relevance
Project Narrative The findings of this project will establish a novel generation of personalized cardiac patch devices for remuscularization of heart with postinfarction LV remodeling. The central hypothesis is that the bioengineered and perfusable cardiac patch can repair ischemic injured heart using minimally invasive technologies. The hypothesis will be tested via a set of mechanistic in vitro and in vivo studies thus, this proposal is relevant to the part of NIH's mission that pertains to fostering fundamental creative discoveries and innovative research strategies as a basis for ultimately protecting health.